Microbiology Track V - Micro Capability/Capacity Development

Microbiology Capability/Capacity Development Project Abstract Tennessee Department of Agriculture's (TDA) goal within this project is to develop the capacity to analyze samples for Cyclospora. This project will leverage existing resources within the Food Safety Section and the Technical Services Laboratory to attain this goal.

Public health relevance
Micro Capability and Capacity Development Project Narrative Tennessee Department of Agriculture (TDA) plans to collect samples and analyze them for Cyclospora. TDA plans to leverage existing resources within the Food Safety section as well as the Technical Services Laboratory to reach this goal.